Understanding how developmental systems compensate for and are affected by change

Project Abstract Animal development is remarkably robust to variation, be it of genetic, environmental, or stochastic origin. It is widely believed that complex systems have evolved to buffer against variation because the consequences of uncompensated variation are severely deleterious to the organism, as in the myriad human congenital disorders that arise because of genetic or environmental perturbations in development. Despite the importance of the systems that make development robust, they remain poorly understood. Little is known, for example, about relationship between the level of robustness and the severity of the phenotype were the robustness to fail. Arguably the most common form of large-scale genetic variation encountered in animal development is sex chromosome dosage. In my research, I use the consequences of and response to differences in sex chromosome dose between males and females of Drosophila melanogaster as a general model for understanding how variation in the gene dose can affect development. I recently developed methods to sequence the mRNA from single Drosophila embryos, which allowed me to discover that many X-linked genes that play an important role in patterning the Drosophila embryo are expressed at nearly identical levels before the canonical Drosophila dosage compensation system is activated. This demonstrated the existence of an uncharacterized, yet widely used, system of dosage compensation in the early embryo. Moving forward, I will A.1) determine the mechanism of early zygotic dosage compensation, A.2) characterize dosage compensation in a species with recently derived sex chromosomes to identify genes with a strong requirement for compensation, and A.3) manipulate gene dose in transgenic D. melanogaster to characterize how variation in early development affects adult phenotypes. The last aim will allow dissection of how variation is propagated or suppressed during development, and form the basis of the independent stage of my research program.

Public health relevance
Project Narrative Animal development is a robust process, able to produce stereotyped outcomes despite genetic and environmental variation. Yet some forms of variation are propagated through development, and can have severe effects, leading to miscarriage and a wide range of congenital abnormalities. Here, I propose to investigate the mechanisms by which developmental processes suppress such variation, and when this suppression fails, how it is propagated through development, and to what phenotypic effect. __SpecificAimsTextDelimiter__ 10. Specific Aims Animal development is a robust process - producing stereotyped outcomes in the face of many sources of variation. However, some perturbations during ontogeny propagate through development, often with serious consequences, while others arrest the process completely. Differences in copy number of regions of the genome are an important source of such variation. In humans, chromosomal aneuploidies lead to miscarriage and a wide range of congenital abnormalities, and there is increasing evidence that smaller copy number variants account for autism and other diseases, as well as variation in "normal" phenotypes. Yet diploid species with dimorphic sex chromosomes (like humans) successfully deal with continuous twofold differences in sex chromosome dose. In my research, I use the consequences of and response to differences in sex chromosome dose between males and females of Drosophila melanogaster as a general model for understanding how variation in the gene dose can affect development. I recently developed methods to sequence the mRNA from single Drosophila embryos, which I applied to generate the first sex-specific timecourse of gene expression during early animal development. I discovered that many X-linked genes that play an important role in patterning the Drosophila embryo are expressed at nearly identical levels before the canonical dosage compensation system is activated, demonstrating the existence of an uncharacterized, yet widely used, system of dosage compensation in the early embryo. Moving forward, I propose to elucidate the mechanisms of this early zygotic dosage compensation system and use detailed studies of the response to dosage variation in transgenic D. melanogaster and species with newly arisen sex chromosomes to determine how variation propagates through development and affects morphology and other important phenotypes. Aim 1. Determine the molecular mechanism of early zygotic dosage compensation I will use single-embryo mRNA sequencing methods to measure sex-specific gene expression throughout early development in a variety of mutant backgrounds, that will test specific hypotheses about the molecular mechanisms involved in the early zygotic dosage compensation system my earlier research uncovered. I will couple these genomic studies with detailed biochemical characterization of implicated proteins and processes. Aim 2. Characterize dosage compensation in a species with recently derived sex chromosomes to identify genes with strong requirement for compensation The neo-X and neo-Y chromosomes of Drosophila miranda are relatively young and are still evolving dosage compensation. I will produce a sex-specific timecourse of gene expression in D. miranda and will use the data to explore the hypothesis that dosage compensation will evolve most rapidly, and under the strongest positive selection, for genes where changes in dosage will have the most severe phenotypic effects. Aim 3. Manipulate gene dose in transgenic D. melanogaster to characterize how variation in early development affects adult phenotypes Building on the results from Aim 1 and Aim 2, I will use transgenic techniques to systematically alter the dosage of genes that are and are not normally dosage compensated, and I will study the effects of these sources of variation on gene expression, embryonic patterning, and larval and adult morphology and behavior. I will begin Aims 1 and 2 under the mentorship of Michael Eisen at the University of California, Berkeley, during which time I will acquire skills in computational genomics and Drosophila transgenesis. Aim 3 will be initiated, as well as Aims 1 and 2 followed up, an independent investigator.